Community Outreach and Engagement

Community Outreach and Engagement (COE) for Winship Cancer Institute of Emory University (Winship) has
been built on a strong foundation of catchment area assessment, community-engaged research, and
dissemination of evidence-based interventions. COE has assessed the cancer burden and priorities in Winship's
catchment area, the state of Georgia,; identified special populations of interest; collaborated with community
partners on strategic planning; established measurable outcomes; and thoughtfully allocated its budget in
support of infrastructure and activities to advance COE goals. The availability of unique resources to support
population-based studies, e.g., the Georgia SEER state-wide registry and regional cancer coalitions, has been
highlighted and strengthened. With the appointment of a new cancer center Executive Director, Suresh
Ramalingam, MD (DDT), and a new associate director for COE, Theresa Gillespie, PhD, MA, RN, FAAN (CPC),
and in collaboration with Winship's Community Advisory Board and statewide partners, Winship COE has
launched a novel series of innovative and wide-ranging endeavors. New approaches have been established to
ensure bi-directional communication with community and patient stakeholders, across the entire cancer research
continuum. Community partnerships inform and guide Winship research program portfolios, clinical trials,
dissemination and outreach, and translation to policy. The overall goal of COE is to facilitate catchment arearelevant
research, including community-engaged research, and disseminate evidence-based interventions, to
reduce the cancer burden across Georgia. This goal will be accomplished through three specific aims: (1) assess,
prioritize, monitor, and communicate catchment area needs and priorities; (2) facilitate and inform Winship
programmatic research portfolios, clinical trials, and strategic planning responsive to catchment area priorities
through bi-directional exchanges with community stakeholders; and (3) disseminate evidence-based
interventions and promote policy impact and translation to the catchment area, nationally and globally. COE
initiated a comprehensive approach to catchment area assessment, priority-setting, and communication
internally and externally. To study underlying basic mechanisms that contribute to poor outcomes in Georgia,
COE hosted discussions on mechanistic models and connected basic, translational, and population scientists
with community and patient advocates, resulting in submission of multiple proposals. COE transformed accrual
monitoring and redesign of the clinical trials process for investigator-initiated studies, so that both patient
advocates and population scientists are directly involved with trials development from the concept phase onward.
To promote dissemination of evidence-based interventions, screening, and clinical trials accrual, COE-funded
FTEs are embedded in regional cancer coalitions to advance research priorities and reduce cancer burden. COE
encouraged adoption of statewide and national policy for impact beyond the catchment area.